B Cell/T Cell Interactions in Brucellosis

Project Summary/Abstract
In humans, Brucella spp. can cause a lifelong, debilitating disease, with relapses of undulating fever and
other complications even with antibiotic treatment. No vaccines are currently licensed to prevent human
brucellosis. In this focused Supplement, we will employ the BSL3 cell sorting capability of the University of
Missouri Regional Biocontainment Laboratory (MURBL) along with RNA-seq to perform detailed transcriptional
analyses of B and T cells in our model of vaccine-mediated immunity to Brucella. Our findings from this
Supplement will complement the results from our parental proposal and provide us additional information which
will enhance our understanding of how B cell antigen presentation inhibits vaccine-mediated immunity against
Brucella, which in turn could improve the rational design of vaccines for brucellosis.

Public health relevance
PROJECT NARRATIVE Brucella infections can cause debilitating disease with relapses of an undulating fever and lifelong complications even with antibiotic treatment, and no vaccines are available for use in humans. We have found B cells enhance susceptibility to Brucella by skewing CD4+ T cell responses, and in the proposed studies we will investigate the mechanisms by which B cells modulate CD4+ T cell responses to impede vaccine-mediated immunity to Brucella infection. Collectively, our results will enhance our knowledge of the pathogenesis of chronic brucellosis and should also have implications for future rational design of Brucella vaccines.